Mechanisms of specification, quiescence, and regeneration of primordial germ cells

Project Summary
We have been successful at isolating primordial germ cells (PGCs) from echinoderms at
different times in their developmental progression. We are now in a position to test the
interactions of PGCs with specific elements of their environment to determine how they become
the gametogenic stem cells. A strength of this model system is an ability to analyze PGC in vivo,
and to compare the different mechanisms between sea urchins (an acquired system of
specification) and sea stars (an induced system of specification). Culturing them both gives us
strong leverage in analysis. We have attempted benchtop culture, manipulations, and passages,
with little success. These cultures quickly become contaminated and the expensive media and
isolation success is for naught.
The research supported by this request is focused on understanding the mechanisms of
formation of primordial germ cells during embryogenesis, how they form during early
development, and how they regenerate when the originals are removed. Our work leverages
embryos from a sister group to chordates – the sea star and sea urchin. While not common
organisms for biomedical research, these echinoderms have many strategic benefits for
revealing unique perspectives in the biology of germline formation and regeneration. Millions of
synchronous embryos from a single male/female cross allow biochemical and metabolic
analysis of the germline, the resultant embryos have ideal transparency for in vivo longitudinal
imaging, they develop rapidly, are easy to manipulate (single cell drop-mRNA-seq,
optogenetics, cell and tissue transplantations) and they are well suited to complementary gene
perturbation approaches (CRISPR/Cas9, morpholino antisense oligonucleotides, MASO), and
small molecule perturbations. The existing deep genomic and reagent resources for these
animals, coupled with their tractable experimental characteristics, yields a unique system for
understanding primordial germ cell biology with defined molecular and morphological endpoints,
in live embryos with longitudinal analysis, distinct metrics of quantitation, and transgenerational
evaluations.

Public health relevance
Project Narrative We request support through this administrative supplement mechanism for a sterile tissue culture hood to replace our previously surplused unit. We did not anticipate being at this point in our research already, but no other options are available to us. The research supported by this request is focused on understanding the mechanisms of formation, maturation, and migration of primordial germ cells during embryogenesis, a process essential for sexual reproduction in animals.